Social and Biological Mechanisms Driving the Intergenerational Impact of War on Child Mental Health: Implications for Developing Family Based Intervention

A. Summary of parent grant
There is a widespread recognition that mental health is often neglected, under-resourced, and
underfunded, particularly in low- and middle-income countries (LMICs) 1, 2. Experiencing traumatic
events as a child is often linked to mental health problems and higher levels of stress reactivity and
impact one's entire ecology with long-term intergenerational consequences 3. The treatment gap, is
more than 50% in all countries and can be as high as 90% in the least resourced countries 4. Sierra
Leone is one of many low and middle-income countries (LMICs) that have encountered challenges in
providing mental health services to their population, particularly children and adolescents 5-6. This has
been compounded by the country's experiences of war and the Ebola outbreak. The parent grant for
the proposed supplement is a mixed-method, longitudinal study evaluating the long-term effects of
war and trauma on parents and their relationships with their children, families, and communities.
Previous studies have noted the limitations of relying on self-reported family dynamics in post-
conflict settings, including Sierra Leone 7. There is a need for observational techniques and
instruments that are context-specific, current, biologically based, and tailored to fathers to supplement
self-report methods. The findings from this study will inform the development of decision-support
tools for lay-worker-delivered prevention models to support family interventions to address specific
needs, based on the family's distinct pattern of risk and protective factors.
Specific Aims of the parent grant: The primary aims of the parent grant are as follows:
(1) Investigate the biological embedding and long-term mental health consequences of war-related
trauma in a longitudinal sample of war-affected youth who have become parents (N=394).
(2) Examine associations between parental war-related trauma exposure, mental health, and biological
and physiological indicators of emotion, cognition, and social functioning in offspring aged 7–24
(N=410). (3) Identify and examine how modifiable risk and protective factors operate to identify
priority intervention targets to improve the physical and mental health of war-affected children and to
develop screening tools to identify families at risk.

Public health relevance
Project Narrative This supplement proposes a two-year research and career development plan that allows Dr. Bah to work alongside mentors, assist on the parent grant deliverables, and conduct his own study aims that are building off of the parent study, “Social and Biological Mechanisms Driving the Intergenerational Impact of War on Child Mental Health: Implications for Developing Family-Based Interventions”, R01 MH128928-01. The aims of the proposed supplement are to explore Sierra Leonean definitions, perceptions, and behaviors that depict positive parental engagement, how they differ between mothers and fathers, and respiratory sinus arrhythmia (RSA) assessment of dyadic interactions. To guide this study, we will explore the social interaction learning (SIL) model that has been used to guide studies on parent-child interactions in a post-conflict setting 11.